Pimavanserin for Insomnia in Veterans with Post-traumatic Stress Disorder

Candidate: Dr. Melissa Beth Jones completed medical school at Drexel University College of
Medicine, psychiatry residency at University of Illinois at Chicago, clinical fellowship in
Behavioral Neurology & Neuropsychiatry at Baylor College of Medicine (BCM), and a research
fellowship in the South Central Mental Illness, Research, Education and Clinical Center
(MIRECC) at the Michael E. DeBakey VA Medical Center (MEDVAMC). She is currently a
faculty psychiatrist in the Mental Health Care Line at MEDVAMC and Assistant Professor of
Psychiatry at BCM. She has published 6 first-authored and 2 co-authored peer-reviewed
manuscripts and 1 first-authored book chapter. Dr. Jones aspires to become an independent
clinician-scientist designing and executing clinical trials of novel interventions for sleep, post-
traumatic stress disorder (PTSD), and other neuropsychiatric conditions impacting US Veterans.
She eventually aims to use these interventions to modify the risk or emergence of
neurodegenerative disorders. Career Development and Goals: During this award period, Dr.
Jones will obtain the necessary training in clinical trial design and execution, biostatistics, and
research assessments of insomnia and PTSD required for her to achieve research
independence as an interventionalist treating these and other prevalent neuropsychiatric
disturbances. This training is accomplished through meetings with her mentorship team, formal
coursework in statistics and pharmacology, and supplemental instruction in sleep medicine.
Environment: The MEDVAMC and Center for Innovation Quality, Effectiveness and Safety
(IQuEST) provide the ideal research and training environments to complete the proposed
project. MEDVAMC provides mental health care to the largest number of unique Veterans in the
country. IQuEST is the premiere center for health services research in the southwest region.
Research: There is a critical need for effective interventions to address the prevalent and
refractory insomnia associated with PTSD. Several lines of evidence suggest that pimavanserin,
a 5-HT2A inverse agonist, may benefit PTSD-related sleep disturbances. Accordingly, Aim 1 is
to conduct a preliminary randomized clinical trial (RCT) of the efficacy of pimavanserin 34mg
administered at bedtime for 8 weeks for the treatment of insomnia in Veterans with PTSD. 48
adult male and female Veterans with chronic insomnia disorder and PTSD are randomized to
receive either pimavanserin 34mg or placebo at bedtime for 8 weeks; mean change in insomnia
severity is compared between groups pre- and post-treatment. While Aim 1 examines subjective
measures of sleep, Aim 2 characterizes objective measures of sleep with polysomnography and
actigraphy pre- and post-treatment. Aim 3 (exploratory) examines whether pimavanserin 34mg
at bedtime for 8 weeks reduces the severity of stress-related psychopathology in US Veterans
with PTSD and insomnia compared to placebo. This pilot RCT informs on the feasibility and
tolerability of our protocol and pimavanserin’s potential impact on sleep architecture. Ultimately,
this proposal provides the framework for a future grant proposal to perform a larger, adequately
powered RCT designed to detect a meaningful clinical difference in insomnia severity following
treatment with pimavanserin.

Public health relevance
Veterans with post-traumatic stress disorder (PTSD) frequently have insomnia (trouble falling or staying asleep). Untreated insomnia carries grave health consequences. Early evidence suggests that pimavanserin (Nuplazid), a medication approved by the Food and Drug Administration for the treatment of psychosis (hallucinations and delusions) in Parkinson’s Disease, may treat insomnia. In this preliminary study, Veterans with insomnia and PTSD will receive either pimavanserin 34mg or placebo at bedtime for 8 weeks, and sleep quality will be compared pre- and post-treatment. Veterans will also complete sleep studies and wear actigraphy watches so we may better appreciate how pimavanserin impacts sleep. Overall, this study will help us understand pimavanserin’s potential benefit for treating PTSD-related insomnia and prepare for a larger, future trial.